Black Men's Brain Health and Aging, Alzheimer's Disease and Related Dementias: Life Course Perspectives

Project Summary/Abstract: The United States has invested significant resources through innovative research to address
the profound effects of Alzheimer’s Disease, and Alzheimer’s Disease and Related Dementias (AD/ADRD) on families and
society, but Black men historically have not experienced the full benefits of scientific advances from that research. For
example, non-Hispanic Black men have diminished health and increased morbidity due to preventable diseases (e.g.,
cardiac, diabetes, high blood pressure) and shorter life expectancies than their White male counterparts Additionally, elderly
Black men are more likely to fall and sustain a TBI than whites, which increases the subsequent vulnerability of brain health
and risk of dementia. Similarly, Black American men might be at increased risk for later-life neurological disorders
associated with exposure to brain injury from contact sports participation, military service, and other sources. Although the
prevalence of AD/ADRD in Black Americans is two to three times higher than in non-Latinx White Americans, a complete
understanding of the causes of this profound health inequality remains elusive. The lack of a highly trained, multidisciplinary
scientific workforce that addresses the full range of biological, biomedical, behavioral, and health sciences approaches to
AD/ADRD health inequities research hinders innovation among this population. This problem is compounded by the
persistent under-representation of Black American males in biomedical research. During this five-year renewal conference
series, leading multidisciplinary national and international scholars will come together with emerging investigators to
address specific cultural, social, and behavioral factors that contribute to some individuals in this population being more
cognitively resilient and experience a reduced risk of developing Alzheimer’s disease than others. Scholars will enhance
the NIA Health Disparities Research Framework (HDRF) with the inclusion of empirically based factors that are responsive
to the Black male experience, as well as focus on efforts to improve recruitment and retention strategies for participation
from this population in aging research. An essential feature of the conference series will be to engage community
stakeholders (e.g., NFL Alumni Association, Global Sports Institute, Black Men’s Health Clinic, Beloved Community
Services Corporation) in multiple aspects of the conference design, planning, and implementation including the selection of
scientists and clinicians, providing feedback on conference presentations, and dissemination. Planning, implementation,
participation, and evaluation of the conference will incorporate individuals from historically underrepresented groups.
The
aims of the renewal conference series are: (1) Host five multidisciplinary conferences that address knowledge gaps, and
identify future priorities in inclusion science, AD/ADRC clinical trials, cognitive reserve/resilience, aging, and AD/ADRDs
health inequalities life course research among Black men; (2) Train a culturally competent workforce that can advance the
science and practice of lifespan brain health optimization for Black men, and to stimulate new life course research focused
on brain health, cognitive aging, and AD/ADRDs among Black men; and (3) Focused and collaborative attention to the
increased representation of Black men in biomedical research. These initiatives align with the goals of the NIA Division of
Behavioral Health and Society Research (BSR), to achieve health equity, and improve the health of all groups.

Public health relevance
Renewal Narrative Despite heightened awareness, stark inequalities in U.S. population-level health outcomes continue to persist. Black men suffer high rates of biological, psychological, and sociocultural vulnerabilities throughout the life course that could uniquely and substantially increase their Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD) risk. Building on the success from the first award period to advance health inequities research via focused and collaborative attention on the increased representation of Black men in biomedical research, inclusion science, and better integration of their unique biopsychosociocultural risk and resilience factors into models of brain health, cognitive aging, and AD/ADRD across the life course.